MDRO Carriage, Transmission, Sequelae, and Prevention in Nursing Homes

Abstract
Overview: MDRO Carriage, Transmission, Sequelae, and Prevention in Nursing Homes
This P01 Program proposal will address critically important questions surrounding the expanding
problem of multidrug-resistant organisms (MDROs) in nursing homes (NH). Of the 1.4 million residents residing
annually in 15,000 U.S. NHs, more than half (65%) are estimated to harbor MDROs. These MDROs not only
impact medically vulnerable residents in NHs, but they can spread to surrounding hospitals and long-term care
facilities, causing significant morbidity and mortality. Despite growing evidence that NHs are major reservoirs of
MDROs, investments to address MDROs in this health sector are lacking. Little is known about sources or
drivers of MDRO transmission, and identification of effective interventions is needed.
This program integrates expertise in infectious diseases, epidemiology, microbiology, pathogen
genomics, human microbiome, statistics, systems science, health economics, and agent-based models to
conduct an unprecedented set of studies on five MDROs in NHs – methicillin-resistant Staphylococcus aureus
(MRSA), vancomycin-resistant enterococcus (VRE), extended-spectrum beta-lactamase producers (ESBLs),
carbapenem-resistant Enterobacterales (CRE) and the newly-emerged resistant fungus, Candida auris. By
leveraging previous and newly-conducted studies, this program will provide one of the largest compilations of
MDRO isolates from NH residents and environmental fomites. A total of 16,000 MDRO isolates and 3,000
metagenomic samples from 50 NHs will be studied using epidemiology, genomics, and simulation modeling as
distinct and synergistic vantage points to elucidate 1) best sampling methods for MDRO carriage and co-
carriage, 2) key sources and drivers of MDRO transmission, 3) major risk factors associated with carriage,
infection, and hospitalization, and 4) high-yield interventions to inform infection prevention policies to mitigate
adverse health outcomes due to MDROs in NHs.

Public health relevance
Project Narrative Overview: MDRO Carriage, Transmission, Sequelae, and Prevention in Nursing Homes More than half of nursing home residents harbor at least one multidrug-resistant organism (MDRO) that can cause significant hard-to-treat infections. This program will combine epidemiologic, genomic, and simulation studies to comprehensively sample and study how five major MDROs spread in nursing homes between residents and the care environment, including in bedrooms and shared common areas. Findings will inform policy and identify high-yield infection prevention strategies to protect the 1.4 million people who reside in 15,000 U.S. nursing homes each year.